Development of a Minimally Invasive Partial Circulatory Support Device for Chronic Use

PROJECT SUMMARY
The Nautilus pump is a centrifugal, totally implantable, compact, long-lasting partial circulatory assist device
implanted via a minimally invasive pacemaker pocket approach to support LV function for late-stage heart failure
intervention. The Nautilus pump will be connected to the systemic circulation by attachment of the pump’s inflow
port to a cannula placed into the subclavian vein and positioned in the left atrium via a transseptal approach, and
the outflow port to a vascular graft anastomosed to the subclavian artery. This revolutionary partial support pump
is being designed to eliminate the need for invasive techniques to implant full support devices (sternotomy or
thoracotomy) and eliminate the need for percutaneous cables and/or drivelines. The Nautilus pump and system
will be a minimally invasive, low energy consumption system that will not impose excessive afterload on the LV,
therefore maintaining pulsatility. Furthermore, it will retain native heart ventricular muscle integrity, offering the
best environment for LV reconditioning. Another feature to be integrated to the pump is the next-generation
transcutaneous energy transfer (TET) system, which does not require direct external coil skin contact to power
the pump. This is a remarkable feature that is not present in any other competitors’ systems.
Leveraging pump affinity laws, which govern centrifugal pump performance and are useful to modify pumps for
new and different required duties, and the Company’s extensive intellectual property portfolio, the Nautilus pump
is being designed based on our full support assist pump. It will combine permanent magnetic levitation with a
low shear hydrodynamic bearing to produce an ultra-low power consumption pump that still retains the superior
blood handling characteristics of full maglev technology. This highly efficient pump is then combined with
implantable grade batteries and a light, external mobile wireless power source, making it a totally implanted and
wirelessly powered system that does not require a percutaneous driveline, direct skin contact, or bulky external
batteries. In-vivo preliminary studies using the full circulatory support pump device validated all the innovative
features in this grant proposal, such as a high-efficiency pump with a low hemolysis rate.
This SBIR Phase I proposed grant objectives are addressed in two specific aims that will be executed for eight
months. In Aim 1, the Nautilus pump will be designed, and a prototype is fabricated to accommodate 2 – 3 L/min
flows at physiologic pressures. In Aim 2, in-vitro studies, using a recirculating blood test loop, will be performed
to determine red blood cell hemolysis, platelet and leukocyte activation, vWF degradation, and function, as well
as overall blood hemostatic potential, compared to our full circulatory support pump and the BPX-80 Bio Pump™
(Medtronic - Minneapolis, MN, US).
The conclusion of the proposed aims will demonstrate the feasibility and hemocompatibility of the Nautilus pump
design. It will set the stage for a Phase II SBIR grant application where the performance, safety, and suitability
of the device will be evaluated in an in-vivo setting, in addition to the development of a transeptal cannula.

Public health relevance
PROJECT NARRATIVE This project aims to develop a centrifugal, totally implantable, compact, long-lasting partial circulatory assist device (Nautilus) implanted via a minimally invasive pacemaker pocket approach to partially support left ventricular (LV) function for late-stage heart failure (HF) intervention. The Nautilus totally implantable partial circulatory assist device is being developed by leveraging our Company’s background in HF treatment, including an extensive intellectual property portfolio on high-efficiency pump design and remote wireless charging capability leading to a totally implanted system. The development of a durable partial mechanical circulatory support (MCS) device that can be implanted without a thoracotomy or sternotomy, is totally implantable with low energy requirements, and can allow patients to be supported on medical-grade internal batteries, would be highly significant, primarily due to eliminating the many complications related to current devices and allowing for earlier implant in the course of the disease with the potential for recovery of the native heart.